TRAINING &CHECK OUT PROCEDURES

New users are taken through a thorough check-out procedure to ensure that they adequately understand use of the spectrometers, data acquisition, and data storage computers, and when necessary, data analysis software. Note: Most of the training is reported as part of the collaborative project reports.